Inhaled Argon during Cardiopulmonary Resuscitation -A Novel Therapy to Improve Vital Organ Function and Survival after Cardiac Arrest

As a board-certified VA anesthesiologist and cardiovascular physiologist, I study protective mechanisms
against ischemia/reperfusion (IR) injury of vital organs ultimately geared to help our often multi-morbid Veteran
patients who are at an increased risk for myocardial infarction and, thus, cardiac arrest (CA). In fact, more than
380,000 patients in the US alone suffer an out-of-hospital CA each year, a leading cause of often debilitating
illness and death worldwide. Timely reperfusion by cardiopulmonary resuscitation (CPR) is of utmost
importance; yet, reperfusion itself paradoxically adds to IR injury, lethal arrhythmias and cell death, and even
with the best mechanical CPR, >90% still have severe neurological deficits or die. Thus, organ-protective
strategies early during resuscitation are desperately warranted. The beneficial effect of ventilating with the non-
anesthetic noble gas Argon (Ar) after successful resuscitation, i.e. return of spontaneous circulation (ROSC),
has been tested in only very few CA studies, none of which, though, has utilized Ar to its full potential of
organ protection when given immediately upon reperfusion, i.e. the very beginning of CPR, to increase the rate
of ROSC, nor have they explored specific mechanisms of action. Despite lack of chemical reactivity due to
completely filled outer electron orbitals, noble gases can exert discernible biological effects by interacting with
signaling proteins, ion channels, and/or receptors. Supported by strong preliminary ex and in vivo data, we
hypothesize that Ar improves survival and neurologically favorable outcome after prolonged CA and extended
CPR by i) decreasing arrhythmias and ii) increasing vital organ perfusion primarily due to pulmonary
vasorelaxation with increased right-to-left blood flow and, thus, increased systemic cardiac output and blood
flow to vital organs during and after CPR. Hence, our revised multi-pronged study has three specific aims:
AIM 1: Define the mechanism by which Ar exerts its anti-arrhythmic effect. In vitro electrophysiological
patch-clamping experiments complement ex vivo optical mapping in rat isolated hearts in the absence/
presence of Ar with or without IR. Experiments in Aim 3 will confirm and quantify the benefit of this effect in
vivo. This provides the first systematic characterization of Ar’s anti-arrhythmic properties.
AIM 2: Define the mechanism by which Ar regulates pulmonary and peripheral vascular tone. Experi-
ments in rat isolated systemic and pulmonary vessels will be scaled up and tested in ex vivo models of isolated
intact hearts and lungs with or without IR and in the absence or presence of Ar and/or putative pathway
agonists or antagonists. Experiments in Aim 3 will confirm and quantify the benefits of these effects in vivo.
This will lead to previously undescribed mechanisms of vascular tone regulations by Ar.
AIM 3: Evaluate the therapeutic potential of early Ar inhalation to improve ROSC, cardiac and cerebral
recovery and survival after prolonged CA and extended CPR. A directly preclinical in vivo survival model
of prolonged ventricular fibrillation, extended mechanical CPR and state-of-the-art neurological assessment in
pigs will complement non-survival and survival CA studies in rats to define clinically relevant effects of early Ar
inhalation on survival and recovery of cardiac and neurological function. A purely postconditioning effect when
Ar is applied only after ROSC will be tested against its immediate administration at the very beginning of CPR.
This revised and further improved, highly innovative proposal by an expanded team of well-established
researchers and physicians in resuscitation science will shed much needed new light on the mechanisms and
qualitative and quantitative effects of organ protection and improved survival by early Ar inhalation after
prolonged CA and extended CPR. It will help develop a completely novel, potentially game-changing therapy in
cardio-cerebral resuscitation, ready to be tested in clinical studies with the potential to significantly improve
survival, functional recovery and quality of life in thousands of CA patients each year, including Veterans, with
otherwise bleak outcomes.

Public health relevance
As a VA anesthesiologist and physiologist, I study desperately needed, novel strategies against cellular injury of vital organs including brain and heart, geared to help our often multi-morbid Veteran patients who are at a higher risk for heart attacks and, thus, cardiac arrest, a leading cause of debilitating illness and death world- wide. Even with the best resuscitation, >90% still have severe neurological deficits or die. Inhalation of the no- ble gas Argon during resuscitation offers an intriguing new therapy to improve neurologically favorable survival by so far unexplored mechanisms. Thus, the improved multi-pronged approach of this revised highly innovative proposal by a team of well-established physicians and scientists in resuscitation will help develop a completely novel, potentially game-changing therapeutic approach in cardio-cerebral resuscitation, that will be ready to be tested in clinical studies with the potential to significantly improve survival, functional recovery and quality of life in thousands of cardiac arrest patients, including Veterans, each year with otherwise very bleak outcomes.